Implementation of Screen, Treat, and Triage for Women Living with HIV in La Romana (iSTAR)

PROJECT SUMMARY
Cervical cancer is preventable, yet it remains one of the most common causes of cancer-related death in
women in low- and middle-income countries (LMICs). Few diseases reflect global inequities as much as
cervical cancer. as incidence and mortality rates are 2-3 times higher in LMICs compared to richer countries.
Further, women living with HIV (WLH) are six times more likely to develop cervical cancer compared to women
who are HIV-negative. Reaching WLH, who are at high risk of developing cervical cancer, requires integration
of preventive screening and treatment services for both diseases (cervical cancer and HIV) to increase
efficiencies and maximize impact. For more than two decades, researchers have investigated alternative
approaches to cervical cancer screening to maximize their impact in LMICs, culminating in strong endorsement
of human papilloma virus (HPV) testing for primary screening in the current World Health Organization (WHO)
guidelines. Importantly, for WLH, among whom HPV co-infection is exceptionally high, approaches known as
“Screen, Triage, and Treat” (iSTAR) have been demonstrated to be safe and effective. The Screen, Triage,
and Treat approach is designed for implementation in a single visit to reduce attrition and to use health care
personnel expertise optimally for maximal efficiency. In response to RFA-CA-23-033, our study seeks to
identify, understand, and develop strategies to address barriers to the adoption, integration, and sustainability
of evidence-based cancer control interventions among persons with HIV in LMICs. To that end, we propose to
use a bundle of strategies (mHealth clinical decision support tool, practice facilitation, and patient education
material) to implement the WHO-endorsed iSTAR approach for cervical cancer screening for WLH in La
Romana, Dominican Republic (DR). The existing cervical cancer screening programs in the DR are inefficient
and ineffective, resulting in one of the highest disease burdens in the world. In response to this need, the
clinical team at Clínica de Familia approached experts in cervical cancer control, HIV, informatics, and
implementation science at Columbia University to assemble a multidisciplinary team to overcome the current
challenges in providing cervical cancer screening for the women attending their clinic. The overall goal of this
project is to sustain implementation of the evidence-based iSTAR approach for cervical cancer screening in
WLH and to generate new data to inform effective and equitable implementation on a wider scale.

Public health relevance
PROJECT NARRATIVE Cervical cancer is the most frequently detected cancer in women living with HIV and is highly preventable if precursor lesions are identified and treated before progression to invasive cancer; yet, it remains one of the most common causes of cancer-related death in women in low- and middle-income countries. The goal of this project is to accelerate the implementation of Screen, Triage, and Treat, an evidence-based cancer control intervention for women living with HIV, by leveraging existing HIV treatment and prevention infrastructure at Clínica de Familia in La Romana, Dominica Republic. Consequently, we aim to generate data that can inform effective and equitable implementation of evidence-based cancer control for persons living with HIV worldwide.